Rapid Hit Generation and Lead Elaboration for SARS-CoV-2 Therapeutics

The novel SARS coronavirus (SARS-CoV-2) global pandemic has taken a strong foothold and it is estimated that it will infect hundreds of millions of people, with millions dying. These estimates underscore the severity of the COVID-19 disease, caused by SARS-CoV-2, yet there are currently no effective treatments that can be administered to infected individuals. Our approach centered around a proprietary structure-based drug discovery engine, which combines rapid screening of a molecular fragment library in a fragment-based drug discovery approach with high-throughput X-ray crystallography. We will discover and develop novel small molecule inhibitors of the receptor binding domain (RBD) of the SARS-CoV-2 viral spike protein S1 subunit (attachment inhibitors), inhibitors of the viral spike protein S2 subunit (fusion inhibitors), and the Nsp14-Nsp10 complex (replication mismatch repair inhibitors). Our approach resolves an important step in early drug discovery, i.e., the generation of reliable, high-quality, target-specific hits that can be advanced to therapeutics development. Our method provides experimental validation and unprecedented ability to visualize 3D protein-ligand interactions in a single step, delivering valuable actionable assets (identification and definition of binding sites and binding pose) for immediate chemistry and biology follow up in early drug discovery. Our goal is to target conserved amino acid residues within these proteins to discover and advance molecules that may inhibit the SARS-CoV-2 proteins and also serve as pan-coronavirus inhibitors. Thus we will create broad-spectrum antiviral therapeutics against multiple coronavirus strains and against the homologous proteins in SARS and MERS, thereby effectively creating treatments for both current and future coronavirus outbreaks. We will determine X-ray crystal structures of the SARS-CoV-2 RBD, S2 and Nsp14- Nsp10 proteins bound to molecular fragments and elaborate these fragment hits into inhibitors through a combination of computational and medicinal chemistry, high-throughput structural biology, and biophysical assays.

Public health relevance
The novel SARS coronavirus (SARS-CoV-2) currently sweeping the globe has reached pandemic status. Estimates of hundreds of millions infected, with millions dying, underscore the severity of the COVID-19 disease. There are currently no existing effective treatments to administer to infected individuals. This proposal aims to deploy our unique drug discovery platform to discover and develop potential therapeutic agents for COVID-19 by targeting SARS-CoV-2 proteins involved in viral attachment, fusion and replication. By targeting key proteins in SARS-CoV-2, that are also conserved in other coronaviruses like SARS and MERS, we aim to develop therapeutic candidates that could also be optimized as pan-coronavirus inhibitors. Thus we will create broad- spectrum antiviral therapeutics against multiple coronavirus strains, providing treatments for both current and future coronavirus outbreaks.